THE DEVELOPMENT OF AN INFANT RHESUS MACAQUE MODEL OF RHESUS CMV INFECTION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The objective of this project is to determine the immunological differences underlying distinct virological outcome in infant versus adult rhesus macaques after RhCMV infection.